Cerebrospinal Fluid Markers Of Aging And Brain Disease

(1) Increased CSF concentrations of phosphotau protein, tau protein phosphorylated at threonine 231, were shown to be an effective biomarker for distinguishing patients with Alzheimer disease from age-matched controls and patients with geriatric major depression. (2): The brain is protected from edema by an intact blood-brain barrier. Damaging this barrier allows plasma salts and protein into brain, accompanied by water, with a resultant edema. This damage occurs following stroke and brain ischemia.